The Role of Dll1 in Specifying the Molecular and Functional Status of Horizontal Basal Cells

Project Summary
A functional decline in smell, which is experienced by nearly three-quarters of Americans by age 80, can
endanger nutritional status, physical safety, and negatively impact quality of life. Unfortunately, there are
currently no effective treatments to reverse age-related hyposmia. This sensory deficit can be attributed to
pathologically deteriorated regions within aged human olfactory epithelium (OE) that are void of olfactory
sensory neurons. Aneuronal regions persist because horizontal basal cells (HBCs), the OE's reserve resident
stem cell population that is capable of giving rise to all OE cell types, remain frustratingly dormant. Activating
multipotent HBCs that endure within aged human OE, therefore, represents a potentially powerful approach to
reverse smell loss. Our laboratory has previously demonstrated that conditional knock out (cKO) of the Notch
receptor, Notch1, in HBCs leads to decreased HBC expression of the transcription factor (TF) and master
regulator of HBC status, p63, and precipitates spontaneous HBC activation. However, to deftly manipulate the
only signaling pathway currently known to regulate the molecular and functional status of HBCs, we require a
deeper understanding of Notch signaling and its role in specifying HBC status. This need is due to the inherent
complexities of the Notch signaling pathway. One aspect of this intricacy includes the ability for a single Notch
receptor type to interact with multiple ligands, each of which can differentially impact cellular differentiation. In
the OE, Notch1 expressed by HBCs can potentially interact with several Notch ligands, including Dll1 that is
also expressed by HBCs and Jagged1 localized to glial-like Sustentacular cells. As my data demonstrates that
HBC-expressed Dll1 and Notch1 do indeed interact, Aim 1 will establish Dll1's effect on the functional and
molecular identity of dormant HBCs (dHBCs) within uninjured OE by (i) quantifying Hes1, a Notch signaling-
dependent TF, and p63 expression following Dll1 cKO in primary mouse HBC cultures. I will also (ii) utilize
fluorescence activated cell sorting to quantify in vivo HBC expression of Hes1 and p63 following HBC cKO of
Dll1. To probe the longer-term functional role of Dll1 in HBCs, I will (iii) quantify the number and identity of
HBC-derived progeny following HBC cKO of Dll1. Because the functional output of Notch ligand-receptor
interactions can be dynamically regulated during tissue morphogenesis, Aim 2 will elucidate the influence that
Dll1 exerts on activated HBCs (aHBCs) in a model of HBC-mediated OE regeneration elicited by direct OE
injury. To do so, I will (i) perform flow cytometry to correlate, with cellular resolution, the relationship between
HBC activity status and Dll1 expression. I will also (ii) interrogate the functional and molecular impact that Dll1
has on regeneration by overexpressing Dll1 in HBCs via viral transduction in the immediate aftermath of OE
injury. In line with NIDCD's mission, this project and its multidisciplinary approach will aid the design of medical
treatments that therapeutically activate HBCs and controllably regenerate the OE to reverse age-related
hyposmia. As a result, I will be well prepared by this fellowship to embark on a career as a physician-scientist.

Public health relevance
Project Narrative Successful completion of these aims will elucidate the impact that the Notch ligand, Dll1, has on the functional and molecular identity of horizontal basal cells (HBCs) prior to and during olfactory epithelium (OE) regeneration. Given the Notch signaling pathway's inherent complexities and the diversity of Notch receptors and ligands expressed within the OE, defining the role that Dll1 plays in specifying HBC activity will allow us to more deftly manipulate the only signaling pathway currently known to regulate HBC status both molecularly and functionally. This, in turn, will contribute foundational knowledge to the development of a treatment that therapeutically activates persistently dormant HBCs found in pathologically deteriorated and aneuronal human OE to controllably reverse age-related hyposmia.